Tri-I Training Program in Metabolomics

PROJECT ABSTRACT
Metabolomics is a rapidly growing area of interest with significant potential to provide
mechanistic insights in the fields of infectious disease, microbiome science, inflammation and
immunology. However, a key barrier to this potential is the conceptually and technologically
unique nature of metabolomics that distinguishes it from other systems level disciplines. This
proposal seeks to address this barrier by developing a structured didactic and laboratory
training program to increase both the conceptual and technological accessibility of
metabolomics to NIAID-funded trainees.

Public health relevance
PROJECT NARRATIVE This R25 proposal seeks to establish a structured didactic and laboratory training program in metabolomics and thereby enhance training of NIAID-funded trainees in this emerging omics- level science.